Emerging Cockroach-associated Biocontaminants in Low-income Households

Project Summary/Abstract
Asthma, a chronic respiratory disease, afflicts millions of people in the U.S. and exacts high financial burden on
the healthcare system. As people spend most of their time indoors, allergic asthma and atopy are frequently
induced by exposure to a variety of indoor biological allergens. Sensitization to cockroaches and chronic
exposure to cockroach allergens are well recognized as important risk factors in the development and prevalence
of asthma in children, especially in low-income urban and rural households. Exposure to bacterial and fungal
toxins, such as endotoxins and glucans respectively, is also linked to pulmonary inflammation and exacerbation
of asthma symptoms. A recent National Health and Nutrition Examination Survey study reported a strong positive
correlation between the presence of cockroach allergens and endotoxins in dust sampled from the homes of
asthmatic children. However, there is a conspicuous gap in our understanding of whether the microbes that
cockroaches disseminate into the home environment re-shape the indoor microbiome and exposome, and
consequently impact indoor environmental quality and health outcomes. Our long-term goal is to identify major
cockroach-associated asthma triggers in the indoor environment, ascertain their impacts on the health of
asthmatic children, and develop sustainable strategies to mitigate and abate their impacts. The goal of this
exploratory study is to elucidate the causal relationships and linkage between the prevalence of cockroaches
and several indoor pollutants of microbial origin. Preliminary results support the central hypothesis that
perennial cockroach infestations degrade indoor environmental quality (IEQ) in high-risk low-income homes by
producing not only a well-recognized cocktail of potent allergens, but also endotoxins, glucans, and mycotoxins
that can exacerbate the impacts of the allergens as asthma triggers. The proposed approach includes two
specific aims: 1)
Determine the causal relationship between cockroach infestations and indoor microbial toxins
,
and 2)
Determine the role of cockroaches in proliferation, vectoring, and sustaining microbes and toxins that are
linked to respiratory disease and asthma
. The project innovates by integrating in-home sampling with
metagenomic, metabolomic, and proteomic approaches to identify novel asthma triggers that contribute to health
disparities, and by using environmental interventions to quantify the effects of cockroach infestations on the
prevalence of microbial toxins indoors. The impacts of this study include improving our understanding of the
mechanisms by which cockroaches shape the indoor microbiome and identifying emerging biological pollutants
that exacerbate respiratory health in low-income cockroach-infested homes. Future directions will explore 1)
the roles and mechanisms of cockroach-associated microbial toxins in exacerbating the impact of allergens in a
mouse model, and 2) the effects of targeted environmental interventions that eliminate cockroaches on reducing
all cockroach-associated contaminants (allergens and microbial toxins) and improving health outcomes in
asthmatic children.

Public health relevance
Project Narrative/Public Health Relevance Cockroaches are well-recognized as the source of potent allergens that trigger asthma, particularly in low- income children in both urban and rural areas that are chronically exposed to large cockroach infestations. Cockroaches also harbor a diverse gut microbiome, but their role in disseminating microbes and microbial toxins in residential environments is poorly understood. By quantifying the effects of cockroaches on the indoor microbiome and their role in spreading harmful bacterial and fungal toxins, this project will contribute to a better understanding of the combined and synergistic effects of cockroach-produced allergens and microbial toxins on human health in disadvantaged communities.